IPREP Supplemental: Increasing safety and inclusion of the IUPUI training environment

Project Summary/Abstract This supplement project addresses the need to create safer and more inclusive research training environments for NIH-supported projects through a novel curriculum that includes modules on bias/harassment/discrimination based on gender, sexual orientation, gender identity, ability, citizenship, and race/ethnicity. The curriculum has the following learning objectives: (1) increase trainee skills to become (self-) advocates when navigating unsafe and unwelcoming environments; and (2) improve the institutional training environment by enhancing mentor skills for recognizing and preventing bias, harassment, and discriminatory events. Curriculum modules, presented separately to trainees and faculty/staff, consist initially of a podcast using narrative to describe an unwelcomed event to help trainees and mentors understand the impact of bias and discrimination in the training environment and ways to mitigate it. After listening to the podcast, participants will engage in in-class activities, which include a case study, discussion, and role play. Through these participatory sessions, participants will develop the tools necessary to confidently communicate about bias and discrimination. The curriculum will be evaluated using a mixed-method design to obtain qualitative and quantitative formative and summative evidence that demonstrates how well the proposed strategies and interventions promote safety and inclusion in the training environment. The most effective components will be institutionalized for use throughout the IUPUI community and made available on the IPREP website for external use.

Public health relevance
Project Narrative This supplement project addresses the need to create safer and more inclusive research training environments for NIH-supported projects through a novel curriculum that includes modules on bias/harassment/discrimination based on gender, sexual orientation, gender identity, ability, citizenship, and race/ethnicity. By attending these participatory sessions, both trainees and faculty/staff will develop the tools necessary to communicate confidently about bias and discrimination.